Living beyond cancer: the short- and long-term cognitive effects of breast cancer and its treatment for cancer survivors

PROJECT SUMMARY
With the rapidly aging population and improved survival rate, the number of breast cancer survivors in the U.S.
is projected to reach 4.4 million by 2030, among which more than 60% of them will be aged ≥65 years. A key
issue facing older cancer survivors is the impact of cancer and its treatment on their cognition. Cancer and brain
aging have both common and distinct etiologies. For example, shared germline genetic heritability was identified
between breast cancer and Alzheimer’s disease (AD) in large cross-trait genetic analyses, while other studies
showed differential regulation of p53 and Pin1 in cancer and AD. Compelling clinical and observational studies
report deficits in cognitive functioning in women diagnosed and treated for breast cancer over the short-term (<2
years), and consistently support acute toxicity of chemotherapies on cognition (i.e., chemo-brain). In contrast,
population studies, often with long follow-up (>10 years), show lower incidence of AD in cancer survivors
compared with cancer-free controls. While these inverse associations have persisted in studies with attempts to
reduce diagnostic and competing risk biases, the possibility of survival bias, which would increase with time
since cancer diagnosis, cannot be ruled out. Until we can determine how breast cancer and its treatment
(chemotherapy, radiation, and hormone therapy) affect cognitive trajectory, we will not be able to improve quality
of life and care for breast cancer survivors. However, most previous research is limited by a lack of (a)
consideration of both the short- and long-term effect of breast cancer on cognition (which may reduce survival
bias for breast cancer with a 5-year relative survival rate of 90%); (b) repeated global and domain specific
cognition measures before and after treatment; (c) focus on the role of post-diagnostic lifestyles in the treatment-
cognition relation; (d) investigation of gene-treatment interactions; (e) and identification of shared and distinct
molecular etiologies of cancer and AD. The overarching goal of this proposal is to comprehensively determine
the association of breast cancer diagnosis and treatment with cognitive trajectory over time, and identify the
intersection of cancer hallmark pathways with AD to inform targeted intervention. This proposal leverages the
unique resources from the Nurses’ Health Study with follow-up of 3,120 breast cancer survivors for >30 years,
and repeatedly collected objective cognitive assessments; and the Gene Expression Omnibus with 2,520 human
brain transcriptomics on AD patients and controls, and addresses the following hypothesis: (1) Women
diagnosed and treated with cancer experience more rapid cognitive decline over the short-term, and (2) Cancer
hallmarks of genomic instability, oxidative stress and inflammation are shared mechanisms between cancer and
AD, but the hallmarks of proliferation and cellular pluripotency are differentially regulated. Dr. Peng plans to
receive training in areas of aging research, cancer survivorship, advanced statistical modeling, and professional
skill development. Together, the scientific and training components of this K01 will position Dr. Peng to become
an independent interdisciplinary investigator specialized in the integration of aging and cancer research.

Public health relevance
PROJECT NARRATIVE Dr. Peng proposes to comprehensively investigate breast cancer and its treatment (chemotherapy, radiation, and hormone therapy) with global and domain-specific cognitive trajectory over time and to characterize cancer hallmark pathways in brain tissues of Alzheimer’s disease (AD) patients and controls to identify intersecting mechanisms for cancer and AD to inform targeted intervention. This research, together with Dr. Peng’s proposed trainings in aging epidemiology, cancer survivorship, and advanced statistical modeling, will enable Dr. Peng to conduct interdisciplinary research to study the deep connections between cancer and aging and to identify interventions targeting common pathways of cancer and AD to prevent both diseases.